GG747 IN FREQUENTLY SAMPLED IV GLUCOSE TOLERANCE TEST

To test whether GG747, a peptide which inhibits amylin binding to its cell surface receptor, will enhance insulin-mediated glucose disposal during an intravenous glucose tolerance test in people with insulin resistance and in patients with NIDDM.